Implementation Mapping to Promote HIV Self-Testing and Linkage to HIV Prevention, Care, and Social Services among New Yorkers of Trans Experience

PROJECT SUMMARY
Transgender women (TGW), and especially those with an ethnic and racial minority status, are in
critical need of tailored and enhanced HIV testing and prevention efforts. TGW are disparately
impacted by HIV but are less likely to get tested for HIV. HIV testing is a critical entry point for the
uptake of HIV prevention (e.g., PrEP) and HIV care and should also be leveraged to provide a link to
other critical social support services, such as mental health and substance use treatment, which, if
unaddressed might interfere with the uptake of HIV prevention and care practices. The proposed
project aims to address these needs by developing a blueprint for the implementation of an evidence-
based intervention, the Online HIV Self-Test Giveaway (OHTG), adapted to the needs of TGW in
NYC. We aim to develop a blueprint for the OHTG adapted for TGW employing the Implementation
Mapping approach and informed by Implementation Science guidelines. Implementation Mapping
offers an ideal framework to guide the development of this process by helping to systematically map
out relevant determinants, performance objectives, and outcomes from multiple ecologic levels,
including that of the adapter, the implementer, and the broader environment, that structurally support
the implementation strategy. Implementation Mapping includes the following four steps, that we will
implement iteratively: (1) identify program adopters and implementers and conducting an
implementation needs assessment; (2) specify adoption and implementation outcomes, performance
objectives, and determinants, and creating matrices of change; (3) choose theoretical methods
(mechanisms of change) and selecting or designing implementation strategies; and (4) produce and
test implementation protocols and materials. The fifth step, the evaluation of the implementation
outcomes will follow the completion of this one-year planning activity. However, we will design this
evaluation as a final step in the Implementation Mapping process. Using Implementation Mapping will
allow us to operationalize adaptation as a process of thoughtful and deliberate alteration of the design
and delivery of OHTG with the goal to improve fit of the campaign with the needs, circumstances, and
culture of TGW, as informed by the community, and with that, strengthen its effectiveness.

Public health relevance
PROJECT NARRATIVE This project aims to enhance the linkage of transgender women (TGW) in New York City (NYC) to subsequent engagement in gender-affirmative biomedical HIV prevention and care, as well as social support services, such as housing, mental health and substance use treatment, which have significant downstream effects on HIV prevention and care outcomes. This project addresses several NIH HIV/AIDS high priority research topics and NIH/OAR goals, including implementation research to ensure timely HIV diagnosis, uptake of PrEP, and initiation of treatment following diagnosis. As TGW are a population disproportionally affected by HIV, this supplement will also reduce health disparities.